Defining targets of protective immunity in Plasmodium vivax using human monoclonal antibodies

Plasmodium vivax (Pv) is a major cause of malaria worldwide and frequently results in illness among active
duty military personnel. It is also an important cause of malaria in veterans because the parasite develops a
latent stage of infection that can relapse years later. Our aim is to develop a vaccine and novel therapeutics
for Pv. The goal for vaccine development efforts is a multi-component vaccine that targets multiple stages of
the Pv life cycle in humans. In this proposal, our focus is on two essential Pv proteins required for parasitic
invasion of red blood cells (in this case, reticulocytes). These are the Duffy Binding Protein (DBP) and the
Reticulocyte Binding Protein 2b (RBP2b). Our approach is to generate human monoclonal antibodies (mAbs)
from individuals with naturally-acquired immunity to Pv. Using B cells from donors with robust immune
responses, we will identify B cells specific for DBP and RBP2b and generate mAbs against these two essential
invasion proteins. We will test whether the mAbs can block the binding of Pv proteins to their receptors on
reticulocytes and if so, whether they can inhibit Pv invasion of reticulocytes in vitro. We will then determine
which Pv protein targets (epitopes) are recognized by the most effective mAbs. We will identify the mAb targets
that are likely to be present in Pv strains globally and thus useful for inclusion in a pan-global vaccine. The
most promising mAbs will then be tested for their ability to protect against Pv blood stage infection in an Aotus
monkey model of Pv infection. Working with our collaborators at the NAMRU-6 primate unit in Peru, mAbs will
be passively transferred to Aotus monkeys and the animals monitored for protection against Pv malaria.
Pending the outcome of our animal protection experiments, we will proceed with further development of a
vaccine candidate (an immunogen) that incorporates the essential Pv targets identified. We will use a novel
animal-based approach to generate stable immunogens known as nanobodies or VHH antibodies. Our studies
will involve a carefully orchestrated collaboration by experienced scientists working on malaria at the Veterans
Affairs Medical Center in Cleveland, OH; Center for Global Health and Diseases at Case Western Reserve
University in Cleveland, OH; Malaria Unit, Institute Pasteur, Cambodia; Walter and Eliza Hall Institute,
Australia; and the NAMRU-6 unit in Peru. Our results will enable progress toward a multi-component vaccine
against Pv. They will also advance the potential of antibody therapies for severely ill individuals and those in
need of sustained prophylaxis during seasonal transmission and tours of duty.
!

Public health relevance
Plasmodium vivax (Pv) malaria is the most widespread malaria infection, with an estimated 2.85 billion at risk and >10 million clinical cases annually. Of the approximately 170,000 active duty soldiers deployed overseas today, at least 10% are in countries endemic for Pv, and malaria is the second most common chronic infectious disease of active personnel. Pv is a concern for veterans because following initial exposure and illness, the parasite develops latent stages in the liver, and relapse can occur up to 5 years after leaving endemic areas. The Military Infectious Disease Research Program has prioritized the development of a Pv vaccine. Results of this research will enable progress toward a multi-component vaccine and novel therapeutics against Pv, thus aiding attempts at elimination, and will also advance the potential of antibody therapies for severely ill individuals and those in need of sustained prophylaxis during seasonal transmission and tours of duty.